Mass General Brigham HeartShare Clinical Center

Project Summary
Heart failure with preserved ejection fraction (HFpEF) comprises approximately half of all HF and is a highly
morbid condition. Pharmacotherapies that are effective in treating HF with reduced ejection fraction have more
modest if any beneficial impacts on HFpEF, potentially owing to heterogeneous definitions of HFpEF and limited
understanding of optimal pathways to target in HFpEF. Our team of investigators has extensive experience in
HFpEF human subjects research. Complementary Dyspnea and Heart Failure Evaluation Programs attract
referral of HFpEF patients as well as dyspneic control patients without HFpEF to the Massachusetts General
Hospital and Brigham and Women’s Hospital (“Mass General Brigham, MGB”). In addition, our team is highly
engaged in assessing therapeutic interventions for HFpEF through robust clinical trials programs. The MGB
HeartShare Team’s PIs are responsible for HFpEF clinical trial conceptualization, design, implementation, and
endpoint adjudication via established core laboratories in echocardiography, cardiopulmonary exercise testing,
advanced cardiovascular imaging, all of which could be used to support HeartShare. Our team also has expertise
in working with MGB-based electronic health record data, population study data, and clinical trials that inform
our understanding of HFpEF. Our group has used comprehensive cardiopulmonary exercise testing (CPET) to
simultaneously quantitate invasive hemodynamics, blood gases, cardiac function, arterial tonometry and gas
exchange patterns during exercise in individuals with conventionally defined HFpEF. We have begun to delineate
contributions of impaired cardiac, pulmonary, vascular, and peripheral musculoskeletal reserve capacity that are
not evident at rest. Our single-center HFpEF phenotyping study already consists of >700 patients with HFpEF
subjected to uniform phenotyping (echocardiography, NT-proBNP, multi-site blood sampling at rest and with
exercise and comprehensive CPET). In Aim 1 we will assemble a collaborative multidisciplinary investigative
team capable of recruiting, phenotyping, and retaining ≥250 HFpEF patients in the HeartShare Program while
also drawing from experience with core lab oversight, bioinformatic expertise in electronic medical record
research, and leadership of network, population cohort, and clinical trial research relevant to HFpEF. In Aim 2
we will refine the diagnosis and subclassification of HFpEF through comprehensive clinical assessment including
multi-modality imaging of cardiac structure and function, perturbational testing with exercise to probe multi-organ
system physiologic reserve and longitudinal remote physiologic monitoring and assessment of frailty and
cognition. We will also expand on our experience with creation of omics-based signatures of pathophysiologic
states in HFpEF and deploy unsupervised machine learning approaches to the derived data. HeartShare will
enhance understanding of HFpEF and our team is poised to translate improved understanding of HFpEF
subtypes into new therapeutic intervention trials in HFpEF.

Public health relevance
Project Narrative (Public Health Relevance) Heart failure with preserved ejection fraction (HFpEF) is a common condition associated with high morbidity and very limited effective treatment options. Our HeartShare Clinical Center Team will leverage experience and expertise in cardiac imaging, exercise-based evaluation, omics-based research, bioinformatics, and geriatrics to comprehensively characterize HFpEF subtypes and advance our understanding of new treatment priorities.